Nanoparticle Tracking Analyzer (NTA) for the Center for Live Cell Genomics

Principal Investigator/Program Director: Haussler, David
Project Summary
The focus of our CEGS Center for Live Cell Genomics is to build new methodology and capacity for
large-scale, long-term, inexpensive, modular, customizable, shared, Internet-of-Things- controlled, reproducible
live cell culture and tissue-based experimental genomics disease models. Tissue models include traditional cell
culture as well as organoid and primary tissue explants obtained from surgery or biopsy. A particular focus is
the integration of organoid factories that support tissue growth and maintenance with external and on-chip
electro- optofluidic analytical modules to become part of an ecosystem that is modeled after open- source
software. This system will use commodity sensors, cameras, and computers linked in platforms that are flexibly
designed using simple, widely available techniques potentially in order to stimulate rapid innovation in
experimental platforms for tissue culture. This novel technology will allow us to address major scientific issues
in neurodevelopment and pediatric cancer. These include questions about what genes contribute to human
brain development, or what specific molecular pathways are disrupted in individual pediatric cancer cases.
Over the first year of our project, it has become clear that in order to advance our research agenda on both the
scientific and technological sides we require an established, multi-modal nanoparticle analysis method.
Specifically, we are facing two challenges. We need to be able to assess the nanoscale extracellular vesicles
(EVs), specifically exosomes, that are being produced in our organoid factories as a measure of organoid cell
types, metabolism, and health. As these measurements need to be carried out frequently over long periods of
time, a fast and relatively easy-to-use technique is required. Secondly, in order to develop optofluidic devices
that can carry out measurements on individual EVs and exosomes and their molecular content, we need to be
able to establish ground truth references against which the performance of these devices can be compared. To
this end, we are requesting supplemental funding to acquire a Nanoparticle Tracking Analyzer (NTA)
instrument that will provide these capabilities throughout our project. An NTA is a unique instrument that
provides multi-modal analysis on populations of biological and inorganic nanoparticles. Pertinent capabilities
include buffer calibration, measurement of EV concentration and size distribution, surface charge
measurements, assessment of labeling efficiencies, and more. As such, an NTA is uniquely suited for our
requirements and will dramatically accelerate the progress of our research as well as expand its outcomes.
1

Public health relevance
Principal Investigator/Program Director: Haussler, David Project Narrative Our CEGS Center for Live Cell Genomics is developing new platforms that provide living cells growing in realistic 3D cultures that mimic actual tissues in the body and incorporate Internet- based remote control and analysis capabilities. We will deploy this technology to perform new, more robust and more reproducible experiments leading to discoveries in neurodevelopmental disease and cancer. With this supplement, we will acquire a Nanoparticle Tracking Analysis instrument to support and accelerate these developments by immediately enabling longitudinal multi-modal assessment of extracellular vesicle (EV) populations produced by cerebral organoids, and by providing indispensable reference data to assist with the development of optofluidic technology that can analyze EVs and their contents on the single molecule level. 1